An intravascular Bioartificial Pancreas (iBAP)

Project Summary
Approximately 3 million Americans and around 24 million people worldwide are affected by Type 1 Diabetes
(T1D). Exogenous insulin injection, allogeneic whole organ pancreas transplantation, and allogeneic islet
transplantation are the most common treatments for T1D. These treatments can achieve glycemic control for
many patients but result in serious complications. A bioartificial pancreas is a promising treatment for T1D
because it contains functional islets. However, previous attempts to develop a bioartificial device have been
severely limited by insufficient mass transfer within the islet chamber. Silicon Kidney LLC has developed and is
commercializing the silicon nanopore membranes (SNM) that achieves high-efficiency blood ultrafiltration while
selectively retaining specific solutes. The ultra-high hydraulic permeability characteristic of the SNM will enable
appropriate mass transport (especially oxygen, glucose, and insulin) within the islet chamber to achieve
optimal islet performance, while the ultra-selective pore characteristic of the SNM enable unprecedented
immunoprotection. The ultimate objective of this Phase IIB SBIR project is to create a clinical-scale iBAP and
complete all pre-clinical testing in order to file for an IND for a future FIH clinical study.

Public health relevance
Project Narrative Type 1 Diabetes (T1D) affects approximately 3 million Americans and incurs a substantial cost to the US health care system. Our multidisciplinary team at Silicon Kidney LLC and the University of California, San Francisco is developing a new intravascular bioartificial pancreas (iBAP) that will improve T1D outcomes, increase patient quality of life, and significantly reduce the cost of T1D on the health care system.